Project 1: Isolation Chemistry of Plants and U.S. Lichens and Biological Evaluation

PROJECT SUMMARY – PROJECT 1
Project 1 at The Ohio State University (OSU) is comprised of taxonomic authentication, isolation chemistry,
biological testing, and compound synthesis components. Specific Aim 1 will involve receiving extracts of
bioactive authenticated tropical plant materials from Project 2 (University of Illinois at Chicago, UIC) and from
the NCI Natural Products Repository for phytochemical work-up in Aim 2, and extracting with solvents
taxonomically authenticated U.S. coastal lichens and their cultured fungal associates (mycobionts), with these
fungi identified from their 18S rDNA sequence. Specific Aim 2 will deal with (a) LC-MS dereplication studies on
active leads following preliminary screening (in order to prioritize samples for activity-guided fractionation); (b)
purification procedures using chromatographic methods (guided by both in-house bioassays and those
elsewhere in the program project); (c) compound structure elucidation, and (d) scale-up isolation, respectively.
The structures of bioactive compounds will be determined using modern spectroscopic methods, backed up by
X-ray crystallography, where necessary. In Specific Aim 3, plant, lichen, and fungal extracts will be subjected
to primary screening against a small panel of cancer cell lines at Core 1 (UIC). The Project 1 bioassays will
involve four already installed rare cancer cell lines (BDCM leukemia, HPAC pancreatic, HT-1376 urinary bladder,
and MDA-T32 thyroid) as well as target-based assays [viz., nuclear factor-B (NF-κB), and mitochondrial
transmembrane potential (MTP), and annexin V-apoptosis testing, in addition to an assay to evaluate samples
for pyroptosis effects]. These assays will be available also for the testing of compounds isolated in Projects 2
and 3 and synthesized in Core 2. A strong collaboration has been established to test promising compounds from
Projects 1-3 at the Nationwide Children’s Hospital, Columbus, OH [NF2 (neurofibromatosis type 2)-associated
vestibular schwannomas and meningiomas]. In addition, selected compounds will be submitted for formulation,
stability, solubility, metabolism and pilot pharmacokinetic studies in Core 2 (OSU), and also tested in hollow fiber
and xenograft in vivo assays in Core 1 (UIC). Assay refinement in Project 1 will be conducted in collaboration
with the biostatistics component of Core A (OSU). Specific Aim 4 will use chemical synthesis to scale up the
supplies of plant, lichen, and microbial-derived compounds and to assist in compound structure elucidation work
using chemical interconversion methods.

Public health relevance
PROJECT NARRATIVE — PROJECT 1 The primary purpose of this part of the Program Project is to discover new cancer chemotherapeutic agents from plants, collected previously from tropical rainforests, in addition to those sourced from the Natural Products Repository of the National Cancer Institute. Also to be examined with this same objective are U.S. coastal lichens and their fungal associates. In order to meet the scientific aims, our group will perform phytochemical, chemical synthesis, and biological studies in a coordinated manner with the other components of this overall project.